Inhaled Vitamin D as a Protectant Against Respiratory Infections and Environmental Pollutants

Viral infections and air pollution rank among the highest threats to lung health. People with higher melanin expression, bear a disproportionate burden of environmental lung diseases and respiratory infections due to higher exposure to air pollution, genetic predispositions, and other factors, such as nutrition, including increased prevalence of vitamin D deficiency. In addition to reduced nutritional intake of vitamin D-rich foods, high melanin levels in the skin of people with higher melanin expression prevent UVB absorption and biosynthesis of vitamin D. Lower vitamin D levels have been linked to higher incidence and severity of chronic lung disease, such as asthma and viral infections, such as influenza. However, oral vitamin D supplementation has shown mixed results in treating lung diseases, potentially due to the inability of reaching the lungs. Therefore, the objective of this proposal is to investigate inhalation of vitamin D as a route of direct delivery to the airways to protect against air pollution and respiratory infections. Preliminary studies I have conducted indicate that vitamin D may act as a membrane antioxidant, upregulate the expression of the antimicrobial peptide cathelicidin, and attenuate oxidative stress and inflammation induced by air pollutants. Based on these data, I hypothesize that inhaled vitamin D can reduce the severity of respiratory infections and abnormal immune responses to environmental pollutants in human bronchial epithelial cells (HBECs). First, I aim to understand how inhaled vitamin D protects the airway epithelium from lung inflammation caused by respiratory infections and environmental pollutants. Using a novel aerosol deliver system I have developed, HBECs will be pre-treated with aerosolized vitamin D before influenza infection or pollutant exposure, followed by characterization of markers of inflammation, oxidative stress, viral load, and immune dysfunction. I will then determine the potential mechanisms behind this through investigation into the membrane antioxidant properties of vitamin D using live cell imaging techniques. Second, I aim to investigate demographic differences in the pharmacokinetics and pharmacodynamics of vitamin D in the airway epithelium to determine the feasibility of vitamin D inhalation as a therapeutic strategy. HBECs from diverse donors will be treated with aerosolized or basolateral vitamin D, and concentrations of vitamin D metabolites and vitamin D-related signaling proteins will be measured over time. Despite established links between vitamin D status and respiratory health, no studies have investigated the use of inhaled vitamin D as a therapeutic or adjunct treatment for airway inflammation. This proposal is innovative as it uses a new in vitro aerosol delivery system to evaluate a novel route of delivery of vitamin D, investigates its membrane antioxidant and antimicrobial mechanisms as a prophylactic against lung inflammation, and determines demographic differences in the pharmacokinetics of this compound. This application is impactful as delivery of vitamin D could provide a potent, cost-effective solution for treating the pulmonary effects of vitamin D deficiency, potentially reducing health disparities associated with environmental lung diseases and respiratory infections.

Public health relevance
People with higher melanin expression are disproportionately affected by environmental lung diseases and respiratory infections, potentially due in part to increased prevalence of vitamin D deficiency. This proposal seeks to investigate inhaled vitamin D as a strategy to counteract the adverse health effects of vitamin D deficiency/insufficiency using a novel in vitro aerosol exposure system. Using organotypic models of differentiated human bronchial epithelial cells, the studies outlined in this proposal will determine the protective effects of vitamin D aerosols against air pollution and respiratory virus infections and determine the mechanisms underlying these effects.